Administrative Core

Administrative Core Project Summary
The overarching goal of the GP IDeA-CTR Administrative Core (AC) is to provide oversight for and
effectively coordinate all research and investigator development activities supported by the Cores. The
AC plan builds on successes in the first funding period. With a Steering Committee (SC) and an Internal
Advisory Committee (IAC) comprising representatives from all partner sites, and an External Advisory
Committee (EAC) of national CTR leaders, we developed effective infrastructure, services, resources, and
community relationships to advance CTR across the Great Plains region. To build a robust network, we
collaborate with research leaders at all partner sites to assess communication, disseminate information on the
GP IDeA-CTR, and establish pathways for building infrastructure at partner sites. Interactions and leadership
at the national level facilitated our ability to expand CTR regionally and at other IDeA sites. These foundational
activities and the approaches proposed in this renewal endeavor to transform the culture at partner institutions
to bolster CTR capabilities, translate laboratory research to measurable health outcomes, and bring community
and clinician-generated ideas and experience back to the lab. Our specific aims are to: 1. Maintain strong
leadership and governance. The PI, core directors, and institutional leadership will have the authority and
credibility to effectively manage personnel, facilities, budget, and resources, in line with institutional and NIH
policies. 2. Enhance the operations and contributions of our effective SC and advisory committees. SC
enhancements will further enable strategic and operational plans, improve access to Core facilities and
services, and maximize GP IDeA-CTR impact across the network. We will maintain our effective IAC and EAC
to advise on strategic plans and add an Academic Public-Private Board to advise on innovative methods to
catalyze CTR and drive findings to the marketplace. 3. Advance overall plans for managing, coordinating,
and supervising the entire range of IDeA-CTR activities to ensure scientific and fiscal flexibility. This
includes development, support, and oversight of administrative staff of the GP IDeA-CTR to promote effective,
timely communications among the lead institution (UNMC) and partners, Core Directors, investigators, and
NIGMS staff. By meeting these aims, the AC 1) Enhances SC capacity to govern programs; 2) Strengthens
communication and dissemination of information on GP IDeA-CTR programs, resources, and services; 3)
Supports a transparent environment that welcomes input from all partners to solve problems, revise goals, and
realign resources; 4) Links resources and individuals to catalyze team science across partners; 5) Oversees
clinical research resources; 6) Advances network-wide plans to reach individuals and providers in rural areas,
as in our Practice-Based Research Network; and 7) Improves GP IDeA-CTR programs, structures, and
governance through regular feedback from a rigorous Training & Evaluation Core, along with consistent IAC,
EAC, and strong Community Advisory Board inputs.